The Role of Sleep in Cardiovascular Health Among Men Living with HIV

Project Summary
Cardiovascular disease (CVD) is a major health concern facing the U.S. population, with the impact of risk
factors accumulating over the lifespan and beginning well before older age. Increasingly, the study of
cardiovascular health for people living with HIV is vital given the growing number of middle- and older-aged
adults living with HIV as a chronic condition and its complex effects on cardiovascular health directly, and
indirectly through HIV's impact on inflammation. In the general population, poor or inadequate sleep has been
linked with increased risk for CVD, in part through its impact on inflammation and other physiological
mechanisms.
In our own work, among sexual minority men living with HIV, poor sleep has also been linked with lower
rates of adherence to antiretroviral (ART) medications. Therefore, the study of cardiovascular health among
people living with HIV requires special consideration of the pathways from poor sleep through worsened HIV
health to increased CVD risk both directly, and indirectly through inflammation (principally, IL-6, TNF-alpha,
and CRP). Further, we hypothesize that, contributing to this larger picture of physiological pathways from sleep
to CVD risk, is a day-level psychosocial-behavioral dynamic whereby experiences of minority stress affect
subsequent ART adherence through the impact of minority stress on sleep. Accordingly, in the proposed
observational, longitudinal study of 240 racially-diverse sexual minority men living with HIV, aged 45-64, we
aim to use longitudinal data to test the hypotheses that poor sleep longitudinally predicts greater CVD risk
among SMM-LWH aged 45-64, in part through the impact of poor sleep on HIV health, and in part through the
impact of poor sleep on inflammation. Additionally, we aim to test the day-level hypothesis that the impact of
multiple, intersecting sources of minority stress (sexual minority stress, racial/ethnic minority stress, and/or
HIV-related stress) on next-day ART adherence in SMM-LWH operates, in part, through the day-level impact of
minority stress on poor sleep.
This proposed study aligns with the growing recognition of the importance of sleep in numerous mental,
behavioral, and physical health outcomes, and also contributes to our understanding of how minority stress
“gets under the skin” (here, through its impact on sleep) to affect physical health outcomes in individuals with
marginalized identities.

Public health relevance
Project Narrative Looking at cardiovascular health for people living with HIV is vital given the growing number of middle- and older-aged adults living with HIV and the complex effects of HIV on cardiovascular health directly, and indirectly through HIV's impact on inflammation. Given the importance of sleep health for a range of health behaviors, including medication adherence, and the well-established link between poor sleep and increased risk for cardiovascular disease (CVD), the proposed study seeks to measure sleep, HIV health, inflammation, and cardiovascular health across a 12-month period in a sample of 240 racially-diverse sexual minority men living with HIV aged 45-64, to test pathways linking sleep to CVD risk through inflammation, and critically, through HIV health. Additionally, findings regarding the effect of daily minority stress experiences on subsequent sleep and next-day medication adherence will also provide insight into how poorer health outcomes emerge and persist in marginalized communities.